MicroRNA-375 regulation of enteroendocrine cell biology in diet-induced obesity and bariatric surgery

PROJECT SUMMARY / ABSTRACT
Enteroendocrine cells (EECs) coordinate a wide variety of signaling networks to maintain metabolic homeostasis.
As a rare secretory cell lineage of the gut epithelium, EECs sense and respond to luminal stimuli by releasing a
diverse array of hormones that control nutrient sensing, appetite, glycemic regulation, and energy balance. Diet-
induced obesity and bariatric surgery have been associated with the dysregulation and restoration of these
hormonal pathways, respectively. Moreover, a growing number of pharmacological strategies have emerged that
target key EEC signaling pathways to treat metabolic disease. However, despite these advances the molecular
mechanisms regulating EEC biology remain incompletely defined. To address this knowledge gap, this proposal
aims to determine the role of an EEC-enriched microRNA (miRNA), miR-375, in regulating the effects of dietary
and surgical interventions on EEC biology. MiRNAs are short, non-coding RNA molecules that respond to
changing environmental contexts and modulate gene expression at the post-transcriptional level. As such,
miRNAs are critical regulators of a myriad of biological pathways, including intestinal epithelial development and
function. Our lab has previously demonstrated that miR-375 is highly enriched both in intestinal stem cells (ISCs)
and along the EEC lineage, and its expression is dramatically reduced by chronic high-fat diet. In addition, our
preliminary data demonstrate significant rescue of miR-375 expression in ISCs following bariatric surgery,
coinciding with increases in EEC abundance and circulating gut hormone levels. Therefore, I hypothesize that
miR-375 exerts context-specific effects on EEC biology during the pathogenesis and amelioration of diet-induced
obesity. The proposed studies will test this hypothesis through an interdisciplinary approach using our lab’s
established colony of miR-375 knockout (375-KO) mice together with cutting-edge genomic and bioinformatic
techniques. In Aim 1, I will assess how the loss of miR-375 exerts diet-specific effects on the distribution of
different EEC subtypes by performing high-resolution single-cell RNA-sequencing (scRNA-seq) of small
intestinal crypts and villi from wildtype (WT) and 375-KO animals fed either a chronic chow or high-fat diet. In
Aim 2, I will determine how miR-375 contributes to surgically-induced EEC adaptations and metabolic
improvements through scRNA-seq analyses of crypt and villus samples from diet-induced obese WT and 375-
KO mice following bariatric surgery or a control procedure. With these single-cell datasets, I will bioinformatically
determine context-dependent changes in overall EEC abundance, subtype distribution (correlated with
circulating gut hormone levels), and gene expression (including identification of candidate miR-375 targets). I
will also validate these molecular findings in vivo through immunohistochemical assays and metabolic
parameters such as body weight and glucose tolerance. Altogether, these findings will further our understanding
of EEC regulation and may provide novel therapeutic targets for the treatment of obesity and its comorbidities.

Public health relevance
PROJECT NARRATIVE To combat the epidemics of obesity and metabolic disease, a growing number of pharmacological strategies have emerged that leverage key hormonal signaling pathways regulated by enteroendocrine cells (EECs), a rare secretory lineage of the intestinal epithelium essential for metabolic health. Despite these advancements, the molecular regulators of EEC homeostasis, especially in the contexts of diet-induced obesity and bariatric surgery, remain incompletely understood. This proposal aims to address this knowledge gap by examining the context- specific roles of an EEC lineage-enriched microRNA molecule (microRNA-375) in the regulation of EEC biology, which may ultimately reveal novel therapeutic targets for the treatment of obesity and its comorbidities.